Inhibition of Hedgehog Signaling as a Therapeutic Strategy for OSCC

Abstract
Oral cancer is a global health crisis. Within the United States alone, an estimated 58,000 oral cancer cases
and over 12,000 related deaths are projected for 2024. More than 90% of oral cancers are oral squamous cell
carcinoma (OSCC). Current treatments have challenges, and more effective treatments are required. Growing
evidence suggests Hedgehog (HH) signaling as one of the key drivers of OSCC progression and metastasis.
HH signaling induces the expression of genes that promote cancer, including those involved in cell proliferation
and migration. HH pathway inhibition (HPI) drugs have been FDA-approved or under clinical trial for treating
various cancers. However, the therapeutic potential of HPI drugs against OSCC is not clearly elucidated. We
hypothesize HPI could serve as a therapeutic strategy for OSCC. To test this hypothesis, we evaluated the
effects of the HPI drug sonidegib on the viability of OSCC cells, which were recently derived from OSCC
cancer patient tissue and adapted to in vitro cultures. Our innovative research design includes OSCC cells
representing current disease characteristics. Our preliminary data show that sonidegib significantly reduces
OSCC cell viability. Thus, our first aim investigates how sonidegib decreases OSCC cell viability. We will
employ imaging and viability assays, as well as gene and protein analyses, to evaluate the effects of sonidegib
on OSCC cells. We will specifically assess reductions in cell proliferation, inflammation, oxidative stress, and
apoptosis inhibition. Additionally, sonidegib can reduce the expression of motility markers, including
Podoplanin, MMP-2, and MMP-9. We hypothesize that sonidegib can inhibit OSCC cell migration. In our
second aim, we will utilize motility assays to determine how sonidegib decreases OSCC cell migration. Our
third aim focuses on determining the synergistic effects of pairing sonidegib with FDA-approved drugs currently
in trials for OSCC but not targeting HH signaling. We hypothesize that these combination therapies will exert a
greater inhibitory effect on OSCC growth and motility compared to individual HPI treatment. We will evaluate
cytotoxic, cytostatic and migratory markers from Aim 1 and Aim 2 to quantify the synergistic effects. We will
employ RNA-seq to identify key driver genes to further understand the mechanism of action of sonidegib on
OSCC cells, both alone and in combination with other drugs. The implications of our research are significant:
by targeting a major pathway involved in OSCC, we aim to improve treatment outcomes and the quality of life
for OSCC patients. We focus on orally available drugs to offer convenient administration and pharmacokinetics
to offer expedite relief to those suffering from OSCC. Together, our work will alleviate the burden of this
devastating disease and pave the way for more effective OSCC treatments. Additionally, the proposal will
serve as an excellent platform for training undergraduate and graduate students at Rowan University in oral
cancer research and cancer drug discovery development utilizing various molecular biology techniques and
bioinformatics.

Public health relevance
Narrative Hedgehog signaling plays a crucial role in the development of oral cancer, a global health concern due to high morbidity and mortality. The Hedgehog pathway inhibition drug, sonidegib, is FDA approved for basal cell carcinoma but its potential for the treatment for oral cancer remains underexplored. We will investigate how sonidegib treatment inhibits oral squamous cell carcinoma (OSCC) cell viability and motility, and combine sonidegib with other treatments to discover more effective ways to treat OSCC and improve patient outcomes.